Antibiotic-mediated improvements in vigilance: mechanisms of action of clarithromycin in hypersomnia syndromes

Abstract
Excessive daytime sleepiness is a common feature of many neurologic disorders, including Parkinson’s
disease, myotonic dystrophy, and multiple sclerosis. In the neurologic disorders of hypersomnolence,
excessive daytime sleepiness occurs as the primary disease symptom, often accompanied by other sleep-
related phenomena such as long sleep durations, pronounced sleep inertia, sleep-related hallucination, and
sleep-related motor dysfunction. For two of these disorders, idiopathic hypersomnia and narcolepsy type 2,
clinical features are indistinguishable and underlying pathophysiology is unknown. However, prior work has
demonstrated that the macrolide antibiotic clarithromycin is more effective at reducing sleepiness than placebo
in these two conditions, although the mechanism or mechanisms by which clarithromycin exerts this effect are
unknown. Reduction in GABA-ergic neurotransmission, changes in resting state brain connectivity,
suppression of soporific, pro-inflammatory cytokines, and alterations in gastrointestinal microbiome
composition are all biologically plausible mechanisms for this effect, but have not been directly tested. In this
work, a randomized, placebo-controlled trial of clarithromycin will be performed in patients with idiopathic
hypersomnia and narcolepsy type 2 to evaluate for mediators of the beneficial effects of clarithromycin on
pathologic sleepiness. The first aim is to identify central nervous system mediators of reduction in sleepiness
by clarithromycin, including modulation of GABA-A receptor activity by cerebrospinal fluid in vitro and changes
in default mode network connectivity via resting state fMRI. The second aim is to probe extra-neuronal
mechanisms by which clarithromycin may reduce sleepiness, including changes in systemic inflammation and
changes in gastrointestinal microbiota composition. For all aims, sleepiness will be characterized in a multi-
modal fashion, with both self-reported measures of sleepiness, primarily the Epworth Sleepiness Scale, and
objective measures of sleepiness, primarily the mean sleep latency measured on the Maintenance of
Wakefulness Test. Each of the proposed mechanisms will be evaluated in relation to change in measures of
sleepiness via mediation analysis to determine which mechanisms mediate clarithromycin’s reduction in
sleepiness. This work leverages the PI and co-investigators’ clinical research expertise in the
hypersomnolence disorders, the unique and highly motivated patient population at the Emory Sleep Center,
and the complimentary expertise of a team of experienced collaborators. This work will impact the
understanding of the central disorders of hypersomnolence and provide a foundation for future drug
development for these and other neurologic disorders manifesting with pathologic daytime sleepiness.

Public health relevance
PROJECT NARRATIVE Pathologic daytime sleepiness is a common component of many neurologic disorders, contributing to morbidity, functional limitations, safety risk, and reductions in quality of life. Current treatment options for pathologic sleepiness are limited, so this work will extend upon the recent discovery that the macrolide antibiotic, clarithromycin, is effective in individuals whose symptoms are refractory to other available treatments. By probing the multiple mechanisms by which clarithromycin may act to increase vigilance and reduce sleepiness, this work will inform understanding of the understudied hypersomnia disorders and provide a foundation for the development of additional novel therapeutics that are urgently needed.